NIDCR DIR Clinical Training

In FY16, the NIDCR DIR Clinical Research Fellowship program supported the training of six dentists in clinical and translational research studying diseases of the craniofacial systems, Drs. Jacqueline Mays, Andrea Burke, Rashmi Mishra, Monisha Billings, Taro Mukaibo (PI: Melvin), and Blake Warner. One trainee completed the NIH-Duke Masters Degree program in clinical research. The trainees participated in the new NIDCR clinical research curriculum and in the NIDCR Fellow's Retreat. Support was provided for scientific meetings to present research projects and interact with scientific colleagues (e.g. American Association for Dental Research, American Academy of Oral Medicine). The trainees also attended NIDCR DIR and NIDCR sponsored seminar series, as well as NIH-wide Clinical Research Seminars.